Pathology Core

Core C: Pathology SUMMARY/ ABSTRACT
The individual research projects comprising this Ovarian Cancer SPORE application require the procurement,
processing, and analysis of histopathological material from patients with ovarian cancer and benign ovarian
diseases. The research projects have needs for frozen and formalin-fixed, paraffin-embedded samples of
tumor and normal tissue. The research projects also need patient-derived xenograft models and organoids to
test the effects of novel drugs and define the mechanisms of drug resistance. The proposed Pathology Core
augments the already established MD Anderson Cancer Center Gynecological Tumor Bank and the P30-
sponsored MD Anderson Cancer Center Centralized Tissue Repository with supporting database and intranet
access. The Core provides for tissue acquisition by experienced gynecological pathologists to assure high-
quality tissues for the investigators participating in this SPORE as well as investigators of other SPOREs.
The goal of the Pathology Core is to provide frozen tissue, paraffin-embedded tissue, histopathological
expertise, tissue arrays, patient-derived xenografts, and organoids related to the specific needs of the research
projects comprising this SPORE proposal. To meet this goal, the following Specific Aims are proposed for this
Core. Aim 1 is to maintain a frozen and paraffin-embedded tissue repository of ovarian cancers, normal
ovaries, and benign ovarian processes (such as cysts and endometriosis). Aim 2 is to provide pathological
review for all clinical specimens utilized in the SPORE projects and to provide histopathological and
immunohistochemical technical services as necessary. Aim 3 is to create tissue microarrays, patient-derived
xenografts (PDXs), and organoid models and maintain a relational SPORE Database. This SPORE Database
will provide for a virtual tissue repository that can be shared electronically with all SPORE investigators.